Research Training in Neuroendocrinology and Metabolism

PROJECT SUMMARY
Neuroendocrinology and metabolism are central to a host of major health issues including obesity, diabetes,
hypertension, cardiovascular illnesses, renal disorders and infertility. In this revised renewal, we have addressed
the concerns raised in review of our renewal application (see introduction), including strengthening the program
for recruiting PhD candidates. The primary goal of UVA’s Research Training in Neuroendocrinology and
Metabolism Program is to provide outstanding, state of the art, postdoctoral research training for tomorrow’s
basic and clinical scientists in the inter-linked fields of neuroendocrinology and metabolism. Support is requested
for 4 postdoctoral training positions per year, for PhD, MD or equivalently qualified young scientists. We strongly
believe that hands-on conduct of in-depth research with an experienced mentor, all within a rich and nurturing
environment, is the most important component of our Program. We offer a broad repertoire of research
opportunities with highly collaborative mentors with rich, diverse backgrounds: PhDs, MDs, and MD-PhDs from
12 different Divisions and Departments. This high quality of mentorship is the key factor in the long-term success
of trainees and the training program. Accordingly, we only include mentors who demonstrate a passion for
training the next generation of scientists. Research training is enriched through a structured educational
framework designed to impart the full complement of knowledge and skills required for a successful research
career. This is achieved by providing trainees with a systematized, well-heeled dynamic program that continually
evolves with scientific progress, examples include: Seminars, Journal Club, Research in Progress, Didactic
Lectures, Grant Brewing Sessions and opportunities for training in courses related to responsible conduct of
research and career development. The administrative structure includes an Executive Steering Committee that
makes training grant appointments, formally evaluates each trainee’s progress, and manages Program design
and direction. To ensure a high level of oversight, a Program Review Committee assesses the operation and
performance of the Program and makes formal recommendations regarding programmatic improvement. This
Program has a strong record of training scientists of diverse backgrounds, who have gone on to establish
successful careers in academic, medical, pharmaceutical, government, and biotechnology environments and to
obtain independent extramural funding to support their training. This strong overall record underscores the rich
research training opportunities, devoted mentors, and stimulating training environment offered by the Research
Training in Neuroendocrinology and Metabolism Program.

Public health relevance
PROJECT NARRATIVE The primary goal of the Research Training in Neuroendocrinology and Metabolism Program at the University of Virginia is to prepare early-postdoctoral fellows for future research careers in the various fields of metabolism and neuroendocrinology. This investment promises availability of the next generation of scientists and investigators that would help fashion newer treatment strategies for a host of important health problems such as obesity, diabetes, hypertension, cardiovascular illnesses, neurological ailments, renal disorders and infertility.